Effects of Transcranial Direct Current Stimulation (tDCS) on Spaced Discourse Treatment for Chronic Post-Stroke Aphasia

PROJECT SUMMARY/ABSTRACT
Aphasia is a brain disorder, most commonly occurring following stroke, that affects multimodal language
abilities. Humans are socially embedded creatures, and thus deficits in communication have dramatic effects
on occupational potential and quality of life. Despite the unequivocal and quantifiable benefits of behavioral
speech-language therapy, they continue to fall short of a cure, or even desired levels of recovery. One way to
increase the benefits of such therapies is to combine them with transcranial direct current stimulation (tDCS).
Although this approach has been shown to improve naming, there is limited knowledge of the extent to which
this neuromodulatory intervention can complement behavioral treatment to benefit discourse skills and
functional communication. This is particularly true for treatment provided on a clinically-feasible schedule (i.e.,
spaced rather than massed practice). In this project, we take an innovative approach to investigate the effects
of tDCS on discourse production in a pilot study of participants with aphasia. We pair active or sham tDCS with
Verb Network Strengthening Treatment (VNeST), a behavioral therapy that has demonstrated significant
discourse improvement using a spaced treatment schedule. Further, we use a tDCS protocol that has
demonstrated benefit with spaced treatment in our preliminary work. AIM 1 determines behavioral effects of
pairing active tDCS with spaced discourse treatment, in comparison to a group receiving identical therapy with
sham stimulation. An additional goal of this project is to acquire neuroimaging data to inform mechanisms of
tDCS effects by identifying graph theoretic network properties related to behavioral change; we use functional
magnetic resonance imaging (fMRI) to identify each individual's language network using an adaptive semantic
paradigm. In AIM 2A, we examine imaging measures as potential predictors of tDCS effect by calculating two
key features of complex networks (integration and segregation) for both task and resting state fMRI. We then
analyze the relationship between these variables at baseline and discourse changes measured post-therapy.
We anticipate that pre-therapy organization more similar to that of a matched control group will predict greater
benefit from treatment, particularly for active stimulation. In AIM 2B, we assess post-therapy changes in the
language network, including changes in functional connectivity for the region targeted by tDCS (inferior frontal
gyrus; IFG). We predict that the betweenness centrality of IFG within this network will increase significantly
during both task and rest for the active stimulation group compared to sham (approaching that of controls), and
this increase will be associated with discourse improvement. Our findings will increase understanding of (i)
tDCS effects on an evidence-based aphasia treatment provided on a spaced schedule, (ii) language network
properties associated with therapy benefit, and (iii) how targeted stimulation changes this network. Thus, we
will provide insight into how tDCS might be combined with current clinical practice, as well as the mechanisms
through which it induces adaptive neuroplasticity to produce meaningful functional outcomes in aphasia.!

Public health relevance
PROJECT NARRATIVE The proposed research is relevant to public health because it will advance understanding of the clinical potential of transcranial direct current stimulation (tDCS) to augment the effects of an evidence-based aphasia therapy provided on a treatment schedule consistent with current practice. Post-stroke aphasia affects millions of Americans and impacts not only communication, but also quality of life. The proposed research is relevant to NIDCD's mission because it will improve the lives of individuals with communication disorders and provide valuable insights into the mechanisms through which tDCS affects the brain, motivating future studies.